Health status outcomes after mitral valve surgery

PROJECT ABSTRACT OF ADMINISTRATIVE EXTENSION
We propose to build on the existing infrastructure of the University of Southern California
(USC) and Saint Luke’s Mid America Heart Institute in Kansas City (MAHI) Linked Clinical
Research Center to perform a series of analyses to better understand the health status
outcomes after mitral valve surgery. The two treatment goals of mitral valve surgery are to
prolong survival and improve patients’ symptoms, function, and quality of life. Despite the
frequency of mitral valve surgery and its intended treatment benefits, little is known about the
health status outcomes of patients who undergo valve surgery. There have been 3 trials
involving mitral valve surgery conducted by the CTSN in which longitudinal disease-specific
health status were collected. This proposed project will leverage the CT surgical expertise at
USC and the methodological expertise in health status assessment at MAHI to assemble a
team uniquely positioned to answer important questions about health status after mitral surgery.
The specific aims of this administrative extension are to (1) leverage the data collected by
the CTSN as a part of 3 multicenter clinical trials to expand our understanding of the trajectories
of health status improvement after mitral valve surgery; 2) identify the patient factors that are
associated with health status improvement (or lack of improvement) after mitral valve surgery, to
better define the heterogeneity treatment benefit based on patient demographic and clinical
factors; 3) explore the impact of post-operative atrial fibrillation—the most common complication
of surgery—to health status recovery; and 4) examine the impact of less common surgical
complications on the long-term health status of patients.
The cardiothoracic surgical team at USC will provide critical guidance on the clinical aspects
of surgery, important complications, and expected recovery. The cardiology and statistical team
at MAHI will primarily construct the analytic plans and execute the analyses. This team has
decades of experience in analyzing disease-specific health status measures in all forms of
cardiac conditions, with Dr. Arnold having specific expertise in the health status of patients with
valve disease undergoing interventions. The CTSN team will also provide methodological
insight on the analysis of health status around the time of valve surgery and will be responsible
for collating and harmonizing the data across the 3 trials. The results from these analyses are
expected to greatly enrich the shared decision-making process prior to surgery, providing key
insights about improvement in symptoms, function, and quality of life based on individual patient
factors and the potential impact that complications may have on this recovery.

Public health relevance
PROJECT NARRATIVE OF ADMINISTRATIVE EXTENSION Patients with mitral regurgitation (a leaky heart valve) often experience shortness of breath, decreased ability to exercise, leg swelling, and fatigue, and we hope that valve surgery will improve these. This project will combine data from 3 large mitral valve surgery trials to try to better understand 1) the impact of mitral valve surgery on patients’ symptoms, function, and quality of life, 2) the demographic and clinical factors that are associated with a better symptomatic response to surgery, and 3) the impact of surgical complications on recovery. These analyses will help surgeons provide more complete information about the risks and benefits of surgery in terms of symptoms and quality of life improvement, so patients will be able to make more informed treatment decisions.